Periodic Fasting, GHR/IGF-1, Multisystem Regeneration, and Healthspan

PROJECT SUMMARY/ABSTRACT
Age is the major risk factor for many diseases including cancer, cardiovascular and neurodegenerative
disease. Biogerontology research is well positioned to help prevent or at least postpone these diseases by
identifying strategies to delay aging and altering its effects on macromolecular, cellular and extracellular
damage so that the degree and type of damage does not reach the threshold leading to disease incidence or
progression. My laboratory has described the beneficial effect of prolonged fasting and fasting-mimicking diets
in promoting cellular resilience and regeneration and organismal healthspan. The data from the previously
funded PO1 resulted in a recently completed 100 patient randomized clinical trial indicating that a periodic
fasting mimicking diet is effective in reducing risk factors/biomarkers for aging and age-related diseases. Here,
we propose to improve these regimens, test their effect on mouse healthspan, and test the hypothesis that
they promote both cellular protection and stem cell-based regeneration in multiple systems. We will study the
effects of periodic use of a newly designed fasting mimicking diet (FMD5) based on that tested in human
clinical trials and of normocaloric protein restriction cycles (PRC) on the aging of the immune and nervous
systems. An important goal of Project 1 will be to determine whether these periodic dietary interventions can
extend healthspan without exerting adverse effects at very old ages. A major effort will be devoted to the
identification of the molecular mechanisms responsible for the effects of periodic fasting mimicking dietary
interventions on the regeneration of hematopoietic and neural stem cells and whether this regeneration results
in a functional rejuvenation of the immune and nervous systems. We anticipate strong synergism between our
project and Project 2, which will investigate the effects and mechanisms of action of the dietary restriction-
mimicking mitochondrial peptide humanin, and Project 3, which will test the hypothesis that the gas H2S is a
central mediator of fasting-depended protection. We predict that the new insights gained from this project will
continue to be translated into clinical trials to identify interventions that are safe and effective in improving
human healthspan.

Public health relevance
PROJECT NARRATIVE We propose to study the healthspan effects of a periodic dietary interventions and investigate the molecular mechanisms linking them to cellular protection and stem cell-based regeneration. We will investigate the effects and mechanism-of-action of a fasting mimicking diet and protein restriction cycles and of inhibition of nutrient signaling genes in cellular protection, multi-system regeneration, and age-related diseases. These studies will contribute to the identification of drugs and dietary interventions to treat, but also prevent, multiple diseases by acting on the aging process and promoting rejuvenation.